Preservation of brain NAD+ as a novel non-amyloid based therapeutic strategy for Alzheimer’s disease

Tragically, there is currently a lack of effective medicines to prevent, treat, or reverse AD, and the problem is
growing exponentially as our population rapidly ages. A large part of the failure to develop effective medicines
for patients with AD is due to the disproportionate amount of resources that have been devoted to pursuing
putative therapeutic targets linked to the largely unsuccessful amyloid hypothesis of AD. Only very recently has
the first anti-amyloid based therapy been conditionally approved, and many major medical centers are declining
to offer this to patients due to serious concerns regarding its safety and efficacy. Thus, it is imperative that we
discover and develop new and complementary therapeutic targets for AD. Aging is well known to be the greatest
risk factor for AD, and it has been demonstrated that brain nicotinamide adenine dinucleotide (NAD+) levels
decrease in people as they age, and even more so in AD. NAD+ is a critical cofactor and energy metabolite in
brain health and function, and we hypothesize that preserving brain NAD+ will prevent, treat, and potentially even
reverse AD-like pathology and behavioral deficits in a preclinical mouse model of AD, known as 5xFAD mice.
Importantly, we have also shown that this mouse model of AD is characterized by significantly diminished levels
of brain NAD+ as well, thereby modeling this important aspect of human AD. We are testing our hypothesis with
a novel small molecule compound (P7C3-A20) that crosses the blood-brain barrier (BBB) and potently and
selectively stimulates activity of nicotinamide adenine monophosphate ribosyltransferase (NAMPT). NAMPT is
the rate limiting enzyme in NAD+ synthesis, and peripherally-administered P7C3-A20 elevates brain NAD+ levels
under conditions of disease or injury that would otherwise deplete NAD+. The protective effect of P7C3-A20 to
preserve NAD+ and thereby block nerve cell degeneration has been demonstrated in multiple preclinical models,
including mouse models of TBI, Parkinson’s disease, and stroke, as well as a monkey model of hippocampal
nerve cell death. Extended daily administration of P7C3-A20 upwards of a year has shown no toxicity or side
effects in any animal system, including monkeys in which extensive pathological analysis across all organ
systems was conducted after 9 months of daily oral ingestion. Three early pathophysiologic features of AD that
are dependent on NAD+ availability in the brain are axonal degeneration, BBB deterioration, and excessively
high death of young hippocampal neurons that arise from adult hippocampal neurogenesis. We propose that
augmenting NAD+ levels in the AD brain will provide a novel means of preventing, treating, and potentially even
reversing AD. We will thus test whether treatment with P7C3-A20 will be effective in early-disease (treatment
from 2-6 months of age), mid-disease (treatment from 6-12 months of age), and late-disease (treatment from 12-
18 months of age) in both male and female 5xFAD mice. Protective effects in these domains will also be
correlated with objective measure of cognitive and neuropsychiatric behavioral function, as well as other classical
pathologic features of AD, including neuroinflammation, tau pathology, and amyloid plaque accumulation. We
predict that P7C3-A20 will preserve brain NAD+ levels and protect axonal structure, BBB integrity, and
hippocampal neurogenesis at each of these disease stages, which will be associated with generally improved
cognitive and behavioral function, as well as reduced damage in the brain. If so, then our results will establish
robust proof of principle for a novel approach to preventing, treating, and possibly reversing AD by preserving
normal NAD+ levels in the brain. Importantly, our results could also establish a basis for future clinical trials with
a compound currently in drug development (P7C3-A20), together with a plasma biomarker of brain nerve cell
degeneration (acetylated-tau) that we have previously established in both mice and humans.

Public health relevance
Alzheimer’s disease (AD) currently afflicts ~6 million Americans, and is growing exponentially with our rapidly aging population. Veterans are at even greater risk for AD because of their high rate of traumatic brain injury. Both aging and AD are associated with decreased brain levels of the essential co-factor and energy metabolite nicotinamide adenine dinucleotide (NAD+), and many of the early pathological processes in human AD are linked to deficient brain NAD+. We hypothesize that preserving levels of NAD+ in the AD brain could be therapeutic at early, mid and late disease stages, and will test our hypothesis with a novel small molecule (P7C3-A20) that readily crosses the blood brain barrier to potently and safely stimulate NAD+ synthesis in the brain. We will administer P7C3-A20 to the 5xFAD mouse AD model, which like humans also has significantly diminished levels of NAD+. Amelioration of AD-like symptoms and pathology will establish a new therapeutic target (augmentation of brain NAD+) for AD, as well as efficacy of a new therapeutic agent in drug development (P7C3-A20).